Associations Between the Dietary Inflammatory Index and MRI Measures of Brain Volume, Markers of Cerebral Small Vessel Disease and PET Imaging Biomarkers of Alzheimer's Disease (beta amyloid and tau)

In the context of a lack of effective treatment for dementia currently, the way forward is the rigorous investigation of modifiable preventive factors such as diet that impact brain aging. Diet plays a pivotal role in the regulation of chronic inflammation, one of the causal pathways leading to dementia. The Dietary Inflammatory index (DII) is a universally applicable tool on diets across the world and is designed to investigate the inflammatory potential of diet on multiple health outcomes ranging from blood concentrations of inﬂammatory cytokines to chronic diseases. This is the first study to investigate the DII in relation to brain volume measures, markers of cerebral small vessel disease, and biomarkers of AD. We aim to investigate (1a) the longitudinal relationships between the Dietary Inflammatory Index (DII) and structural magnetic resonance imaging (MRI) markers of brain aging (i.e. total brain volume, hippocampal volume, lateral ventricular volume, and total grey matter volume) among participants (n=2,500) in the Offspring cohort and the Omni 1 cohort of the Framingham Heart Study (FHS); (1b) the longitudinal and cross-sectional relationships between the DII and markers of cerebral small vessel disease (i.e. white matter hyperintensities, silent brain infarcts, cerebral microbleeds (CMB) and peak width of skeletonized mean diffusivity (PSMD) in this cohort; (1c) mediation effect by plasma inflammatory markers if significant associations are found in aim 1a and aim 1b. Secondly, we will investigate (2) the cross-sectional relationships between the DII and positron-emission tomography (PET)-imaging biomarkers of Alzheimer’s disease dementia (AD), including beta-amyloid PET (specifically, fronto-lateral-retrosplenial) and Tau PET (specifically, entorhinal cortex and inferotemporal cortex) among participants in the Offspring Cohort of the FHS (n=60). Sample for aim 1 will include FHS Offspring (who attended exam 7 and either exam 5 or 6) and Omni 1 (who attended exam 1 and 2) participants who filled out the Food Frequency Questionnaire (FFQ) for the creation of an averaged DII, who underwent brain MRI (Offspring: exams 7,8 and 9; Omni 1: exams 2 and 3) and have data on covariates. Sample for aim 2 will include FHS Offspring participants (who attended exam 7 and at least exam 5 or 6) who filled out the FFQ, underwent beta-amyloid and Tau PET scans at exam 9, and have data on covariates. We will relate the DII to changes of structural MRI markers of brain aging as well as markers of cerebral small vessel disease using multivariable linear regression and logistic regression models. When significant associations are found, we will perform mediation analyses to investigate the role of plasma inflammatory markers. In addition, we will relate the DII to PET-imaging biomarkers of AD using multivariable linear regression models. We will adjust for age at MRI/PET Exam, age squared at MRI/PET Exam, sex, education, Apolipoprotein e4, ethnicity, body mass index, smoking, physical activity (MRI only), total energy intake, time from Exam to Exam MRI/PET, anti-inflammatory medication, diabetes status, history of cardiovascular disease and total to HDL cholesterol ratio.

Public health relevance
In this project, we are planning to test the effect of inflammatory and anti-inflammatory components in the diet on the brain of participants in the Framingham Heart Study. We will assess the inflammatory potential of the diet using an index called the Dietary Inflammatory Index and assess brain effects using MRI and PET scans. Results from our study will provide important information for future dietary intervention trials for brain aging and dementia.